SELF REACTIVE T CELLS IN MURINE LUPUS

NZB/NZW mice spontaneously develop a systemic autoimmune disease similar to human systemic lupus erythematosus. Mature autoreactive T cells have been isolated from these animals. The functional characteristics of these cells suggest that they may play an important role in induction and development of the NZB/NZW autoimmune and autoantibody secretion, an activity that might well explain the elevated immunoglobulin and autoantibodies seen in vivo. We propose to investigate the phenotypic and functional characteristics of these cells in vitro and in vivo. We shall determine their cell surface phenotype and the level of diversity in the T cell antigen receptors expressed by the cells. The antigenic specificity and the functional consequences of activation of these cells will be analyzed. What lymphokines are elaborated upon activation and what subsets of B cells are responsive to the lymphokines? Does activation of B cells require cell to cell contact? The role played by these T cells in vivo in the development of systemic autoimmunity will be analyzed by a) adoptive transfer of the cells to young NZB/NZW mice, prior to development of spontaneous disease, b) by evaluating the effects of immunotherapy using monoclonal antibodies reactive with autoreactive T cell antigen receptors and c) by development and analysis of NZW mice transgenic for T cell antigen receptors expressed by the autoreactive T cells. The transgenic mice will be bred so that the transgenes are expressed on both a normal and a autoimmune background, and these mice will be compared. The information obtained from these studies will provide information on the mechanisms by which self tolerance is achieved and maintained in healthy animals, and will contribute to an understanding of why these mechanisms fail in both human and murine lupus.